Core A: Administration

PROJECT SUMMARY/ABSTRACT
Administration Core
Core A
The centralized administrative infrastructure in Core A provides grant management and fiscal oversight for all
elements of the Program Project, administrative assistance to the Project Leader, and facilitates clinical trial
development, activation and performance for all Projects and Cores.

Public health relevance
PROJECT NARRATIVE Administration Core Core A By providing centralized essential administrative support and budgetary oversight, this Core assists all Projects and Cores on this Program Project Grant in achieving their overall goal of developing improved therapies for patients with hematological malignancies, focusing primarily on adoptive cell therapy and hematopoietic cell transplantation.